Uncovering Mechanisms of Racial Inequalities in ADRD: Psychosocial Risk and Resilience Factors for White Matter Integrity

PROJECT SUMMARY
The goal of this fellowship is to prepare the applicant, Jordan Palms, for a career as an independent
clinical researcher elucidating disparities in brain health and Alzheimer’s disease and related dementias (ADRD).
The proposed project consists of a research study examining the impact of racially patterned social stressors
on white matter integrity within and across racial groups in two cohort studies, as well as a training plan consisting
of hands-on research, mentorship, coursework, and professional development. Jordan will be supported by a
strong mentorship team with primary sponsors within the University of Michigan’s Department of Psychology
and consultants from Columbia University. The mentorship team will provide expertise in ADRD disparities,
neuroimaging, neuropsychology, and advanced statistical analyses. The training plan will help Jordan
develop expertise in 1) biopsychosocial mechanisms underlying racial disparities in ADRD, 2) processing of
MRI images to characterize ADRD risk, 3) advanced statistical analyses, including moderation and causal
mediation, and 4) disseminating findings and collaborating via manuscripts and conference presentations.
Stark racial disparities exist within cognitive aging and ADRD. With limited treatments, identifying potential
modifiable factors that increase risk or resilience for ADRD is necessary to develop interventions aimed at
reducing disparities. Racially patterned social stressors (e.g., discrimination) have been theorized to be a driving
force for these inequalities through multiple pathways. On interpersonal and societal levels, these stressors
disproportionately affect non-Hispanic Black older adults in their risk for ADRD. Identifying the brain mechanisms
in which these psychosocial stressors impact ADRD risk (i.e., white matter integrity) can provide direction towards
intervention targets and treatments. However, little is known about how psychosocial stress leads to ADRD
disparities. Thus, the present study aims to examine whether 1) discrimination is associated with white matter
integrity among non-Hispanic Black adults, 2) external perceived control mediates Black-White disparities in
white matter integrity, and 3) neighborhood social cohesion serves as a protective factor for racial inequalities
in white matter integrity. These aims will be examined in the Washington Heights-Inwood Columbia Aging
Project (WHICAP), a racially and ethnically diverse cohort of older adults in northern Manhattan, and the Michigan
Cognitive Aging Project (MCAP), a racially balanced cohort of non-Hispanic Black and White adults
transitioning to late life in Southeast Michigan.
The proposed study aims address both the NIA Strategic Directions for Research in Aging and the NIA
Health Disparities Research Framework, which call for the consideration of biopsychosocial factors in
examining racial disparities in ADRD. The findings could be useful in designing and implementing
interventions to reduce racial disparities in brain aging and ADRD.

Public health relevance
PROJECT NARRATIVE Evaluating the impacts of interpersonal- and societal-level stressors on brain health is important for understanding the mechanisms that may be driving stark racial disparities in Alzheimer’s disease and related dementias (ADRD). The proposed project will examine the impact of racially patterned social stressors on white matter integrity, an indicator of brain health and ADRD risk that may be particularly relevant for minority populations. It will also quantify the extent to which psychosocial stressors explain racial disparities in white matter integrity and whether neighborhood social cohesion can mitigate the impact of these stressors. Results of the proposed study could lead to more targeted interventions to reduce ADRD risk and racial disparities.